Social Microbiome Assembly, Function, and Impacts on Host Health

PROJECT SUMMARY
Human health is profoundly impacted by our social interactions and our associated microbes. Social isolation
and microbiome perturbations are both linked to a myriad of pathologies including neurological and
immunological disorders. Emerging evidence reveals that our microbiomes are shaped by our social interactions.
For any social animal, we can define its associated microbial community that assembles through social
interactions as its social microbiome. We propose to establish a Social Microbiome Program at the University of
Oregon to investigate the hypothesis that social microbiomes are major drivers of host health and sociality. Our
team’s pioneering research, using a new zebrafish model for the precise manipulation of host social and microbial
interactions, reveals that social microbiomes promote normal host development and mitigate the virulence of
microbiome members. Our recent work has revealed that social microbiomes are enriched for shared, co-
occurring networks of bacteria. We hypothesize that these bacterial consortia are co-adapted to the host
environment, with expanded collective capacities to utilize abundant resources, such as extracellular glycans,
and to overcome nutritional scarcities, such as limiting iron. We show that bacterial processing of host glycans
contributes to features of host neurodevelopment important for social behaviors. Furthermore, we show that
microbiome provisioning of scavenged iron mitigates bacterial virulent tendencies toward host tissue destruction.
We hypothesize that in the absence of these bacterial activities in social microbiomes, neurodevelopmental
social deficits and sickness behavior impair social microbiome assembly and select against bacterial traits
important for host co-adaptation and co-evolution. We will test these ideas about the assembly, functions, and
health impacts of social microbiomes through a coordinated, multidisciplinary research program. Our team brings
together leaders in the areas of microbial ecology, neurodevelopmental biology, animal and bacterial behaviors,
and bacterial pathogenesis. Together we will innovate new approaches to studying microbiomes in animal social
groups.

Public health relevance
PROJECT NARRATIVE Recent changes in the microbiomes of humans in industrialized societies are linked to increased incidence of neurological and immunological disorders, but the specific microbial contributions to this erosion of health are unknown. We hypothesize that for social animals, like ourselves, the microbial communities that assemble through host social interactions – termed social microbiomes – are major drivers of host health because they are enriched for microbial consortia co-adapted to living with healthy, socially interacting hosts. We will discover the assembly processes, functions, and health impacts of social microbiomes using a zebrafish model that allows for precise control and analysis of host and microbial interactions, investigated through a multidisciplinary research initiative conducted in a new Social Microbiome Program at the University of Oregon.